StatWiseAI: An AI-Powered Educational Tool for Enhancing Methodological Rigor in Large-Scale Data Analysis

Abstract: The analysis of complex, large-scale datasets is critical for advancing biomedical and behavioral
research but is often hindered by limited access to statistical expertise and resources. Artificial intelligence (AI)
offers a promising solution by providing tailored, scalable, and accessible guidance to researchers, enabling
them to overcome these challenges. This R25 proposal responds to RFA-DA-25-039: Education Activities for
Responsible Analyses of Complex, Large-Scale Data. The overarching goal is to develop, evaluate, and
disseminate StatWiseAI, an AI-powered educational tool that supports methodological rigor in analyzing
complex datasets involving brain, behavioral, genomic, and socioenvironmental data. By leveraging OpenAI’s
GPT-4, StatWiseAI will provide tailored, expert-informed guidance to researchers, enhancing their ability to
conduct rigorous, reproducible, and ethically grounded analyses. This project has three specific aims.
Aim 1: To develop StatWiseAI as an AI-powered educational tool for rigorous data analysis. We will
curate domain-specific knowledge, fine-tune GPT-4 using expert-verified case studies, and design interactive
features that allow researchers to explore advanced analytical methods relevant to their disciplines. Aim 2: To
evaluate StatWiseAI through pilot testing among NIH investigators. The evaluation will focus on usability,
content quality, and feasibility, using both subjective measures (e.g., user feedback) and objective measures
(e.g., AI-generated response quality compared to ChatGPT). Insights from the evaluation will inform iterative
refinements. Aim 3: To disseminate StatWiseAI and assess its long-term impact. We will implement
StatWiseAI across diverse NIH research communities, collaborating with NIH training programs and leveraging
professional conferences. Regular updates will ensure the tool remains technologically and scientifically
current, meeting evolving user needs.
StatWiseAI is distinguished from generic AI tools like ChatGPT through its integration of curated
resources, expert-verified case studies, systematic prompt training, and periodic expert reviews. It offers a
unique educational experience, helping users build AI literacy alongside content expertise. The tool is designed
to address common pain points researchers encounter, including integrating disparate datasets, mitigating
biases, and navigating advanced statistical methods. The proposed project builds on the PD/PI’s extensive
expertise in AI integration, behavioral science, and health informatics. The interdisciplinary team includes
experts in neuroimaging, genomics, behavioral science, biostatistics, AI ethics, and computer science,
ensuring comprehensive support for StatWiseAI’s development and dissemination. StatWiseAI will transform
the way researchers approach complex data analysis, reducing barriers to statistical expertise and fostering a
research culture of enhanced methodological rigor, reproducibility, and innovation. By empowering researchers
across all career stages, it will contribute to advancing the field and producing high-impact, reliable science.

Public health relevance
Public Health Relevance StatWiseAI will enhance health science researchers’ ability to analyze complex, large-scale datasets with methodological rigor, reproducibility, and ethical integrity. By providing tailored, expert-verified guidance, the tool will empower researchers across all career stages (e.g., advanced graduate students, postdoctoral fellows, junior, mid-career, and senior faculty) to produce high-impact, reliable science addressing critical public health challenges. This initiative will contribute to advancements in biomedical and behavioral research, ultimately improving health outcomes and reducing disparities across diverse populations.